High-Throughput De Novo Glycan Sequencing

Awarded Abstract: Glycosylation fulfills important physiological functions, including protein folding, embryogenesis, cell adhesion, pathogen recognition, and immune response. The multifaceted roles glycosylation plays derive from the presence of a range of glycan epitopes, where a small structural variation can have a profound impact on functions. Further, a glycome consists of many closely related structures, with their relative amounts determined by metabolic conditions in a cell- and growth-specific manner. Altered glycosylation is linked to many diseases, including cardiovascular, pulmonary, neurological and autoimmune disorders, and cancer. Thus, there is a clear need for analytical methods that can rapidly identify and quantify the many glycoforms in a glycome from different health and disease states. Finally, no genome-predicted glycan database exists due to the unscripted nature of glycan biosynthesis, and discovery of new glycan structures must be achieved by de novo methods. Although tandem mass spectrometry-based biopolymer sequencing has been the major catalyst to the recent rapid advance of 'omics, the prevailing collisionally activated dissociation method often fails to provide sufficient glycan structural detail at the MS2 level, whereas the MSn approach lacks the speed, sensitivity, and quantitative potential for high-throughput glycome analysis. We have recently developed an electronic excitation dissociation (EED) method that can yield rich structural information in a single stage of MS/MS analysis. However, the impact of EED on glycomics research is currently limited by its poor accessibility, insufficient coupling to on-line glycan separation methods, and difficulty in interpretation of complex glycan EED tandem mass spectra. Here, we propose to develop an integrated approach that combines EED with on-line liquid chromatography (LC) separation and a novel bioinformatics tool to achieve high-throughput, de novo, and comprehensive glycome characterization. We will explore the potential of EED for analysis of glycans in various derivatized forms, study their fragmentation behaviors, and establish fragmentation rules for the development of bioinformatics software. We will optimize conditions for efficient coupling of EED to reversed-phase, and porous graphitic carbon LC, and develop an LC-EED-MS/MS approach for simultaneous characterization and quantitation of glycan mixtures. We will implement EED on a Q-TOF instrument to improve its access to the glycoscience community. Finally, we will develop and rigorously test the performance of a novel bioinformatics software that can rapidly and accurately determine each glycan's structure from its tandem MS spectra. The proposed algorithm is fundamentally different from most existing software, in that it no longer relies solely on glycosidic and cross-ring fragments for topology and linkage analysis, but rather adopts a machine learning approach that considers the contexts of various types of fragment peaks, and the spectral features associated with different linkage configurations and structural motifs. The availability of such a high-throughput, de novo glycan sequencing tool will have an immense impact on many biomedical research fields, as glycosylation plays critical roles in almost all biological pathways.

Public health relevance
Awarded Project Narrative Characterization of glycans from biological sources requires sensitive and high-throughput analytical methods that can separate and identify each glycoform in a complex mixture. We propose to develop an HPLC-EED- MS/MS method for comprehensive glycome characterization. We will also develop a novel bioinformatics program that can accurately determine the glycan structure from its EED tandem mass spectrum de novo.